Expanding Ohio's Testing Capability and Capacity to Support a National Integrated Food Safety System

Expanding Ohio’s Testing Capability and Capacity to
Support a National Integrated Food Safety System
Overall Component
Project Summary / Abstract
The Ohio Department of Agriculture (ODA) Consumer Protection Laboratory (CPL) and Animal
Disease Diagnostic Laboratory (ADDL) will strengthen the national food supply chain and
enhance federal and state regulatory effectiveness in food safety and defense, supporting the
Food Safety Modernization Act and the Food Emergency Response Network. The agency
proposes to participate in all chemical and microbiological US FDA initiated food defense
activities related to animal or human food including proficiency tests, surveillance activities,
triage exercises, national security event exercises and any other testing as requested by the FDA
where suspected or credible threats to the food supply are present. CPL will maintain
operational readiness in supplies, instrumentation and personnel should they be activated for a
rapid response. ODA-CPL will also participate in state-initiated product testing of human and
animal food products, testing up to 7,000 samples over five years for microbiological and
chemical targets according to FDA directed commodity/hazard pairs. ODA-CPL will
incorporate and implement routine Hepatitis A / norovirus screening and incorporate
additional non-targeted toxin testing in human or animal food products. ODA-ADDL will
enhance the FDA’s GenomeTrakr network and the National Center for Biotechnology
Information’s Pathogen databases through Whole Genome Sequencing (WGS) and uploading of
at least 400 different human food, animal food or environmental isolates, providing support for
other state and federal partners and participating in any method validation studies as requested.
ODA-CPL is committed to participating in up to two method development activities per
discipline per year when funded, and intends to increase capacity and capability of both
disciplines through equipment refreshes, automation, instrumental upgrades and entirely new
technology. Based on the current funding opportunity, the agency requests $1,331,100 in project
period 1 for samples, supplies, payroll, services and equipment as needed to support all projects
proposed and up to $6,000,000 in additional funding as currently offered by FDA for the
remaining project periods.

Public health relevance
Expanding Ohio’s Testing Capability and Capacity to Support a National Integrated Food Safety System Overall Component Project Narrative Federal and state collaboration is essential to a secure, national integrated food supply, and the goals of increasing sampling numbers, contributing to the national genome and food safety databases and incorporating new or improved methods directly impact the effectiveness in fulfilling the mission of the Food Safety Modernization Act. Increased capability and capacity will improve state and federal incident response speed through faster testing turnaround times, improved interagency communications, more defensible data and provides for immediate regulatory action to prevent or reduce the scale of harm from any present or future scenario involving state, federal or local agencies.